Implementation and Sustainment of Team-Based Practice Transformation to Improve Heart Failure Care and Outcomes

PROJECT SUMMARY
Heart failure (HF) is a costly and complex health condition affecting millions of Americans. HF care is often
fragmented which negatively affects quality, safety, and patient-centered outcomes. Structured Interprofessional
Bedside Rounds (SIBR) is a model of care developed to bring interprofessional team members together with
patients and families using a structured format to collaboratively arrive at a daily care plan. The SIBR model is
characterized by four core components: an interprofessional approach, utilization of a rounding structure,
intentional patient and family engagement, and development of a shared daily care plan. A growing body of
evidence associates SIBR implementation with improvements in team and patient outcomes. The hypothesized
mechanism through which SIBR operates is that having a predictable structure leads to improvements in
communication, fewer gaps in care, and more consistent utilization of evidence-based approaches. These
changes are thought to lead to improvements in patient outcomes such as, length of stay, readmission rates,
patient-centeredness of care, and safety/adverse events. Despite frequent improvements in outcomes following
SIBR implementation, an evidence gap exists as to the role that fidelity (adherence) to the SIBR model plays in
how and why this model works and the extent to which outcomes can be further improved if fidelity is higher. To
address this knowledge gap, this proposal leverages a timely opportunity to study SIBR fidelity and its
relationship to care and outcomes among patients with advanced HF at the University of Washington Medical
Center, where a SIBR model has been the standard of care for 4+ years. The central hypothesis is that higher-
fidelity SIBR will be associated with better outcomes. To test this hypothesis, I will carry out a prospective cohort
study to achieve three specific aims: (1) identify associations between SIBR fidelity and patient outcomes, (2)
determine the extent to which SIBR fidelity predicts time to initiation and completion of an evidence-based
“Advanced HF Work-Up Pathway”, and (3) examine patient and family experiences of care quality and safety in
the context of higher- and lower- fidelity SIBR. These aims will lay the groundwork for an initial multi-site R01 to
study SIBR in practice and a future R-level grant to implement and evaluate an optimized SIBR model. Through
this work, I will obtain formal training in HF outcomes research, advanced implementation science study designs,
and patient-oriented clinical research methods. I will be mentored by an expert team of NHLBI-funded
researchers, Bryan Weiner (primary mentor, implementation science), Randall Curtis (communication and
palliative care), Brenda Zierler (interprofessional collaboration and clinical pathways), and Kevin O'Brien
(advanced heart failure care). The combination of mentorship, coursework, and experiential learning will position
me to become an independent investigator using scientifically rigorous approaches to evaluate the
implementation and outcomes of evidence-informed patient- and family-centered models of care.

Public health relevance
PROJECT NARRATIVE Heart failure (HF) care is costly, complex, and often fragmented which impacts quality of care, safety, and other patient outcomes. Structured interprofessional bedside rounds (SIBR)—a model that was developed to bring together health professionals and patients using a structured format to collaboratively arrive at a daily plan of care—has been associated with improvements in many care team and patient outcomes but model fidelity (adherence) varies. Rigorous study of SIBR fidelity when analyzing impacts on care and outcomes is needed to determine whether and how SIBR can reliably lead to improvements.